Mechanisms of Pesticides-Induced Neuronal Apoptosis

DESCRIPTION (provided by applicant): Parkinson's disease (PD) is the second most common aging-related neurodegenerative disorder. It is characterized by selective loss of dopaminergic neurons in the substantia nigra pars compacta (SNpc) of the brain. Despite intense research in the past decade, mechanisms underlying the selective dopaminergic neuron death have not been well defined. Although inhibition of complex I activity is one of the leading hypotheses for dopaminergic neuron death associated with PD, this hypothesis has not been tested genetically. Our collaborator, Dr. Richard Palmiter, recently generated a transgenic mouse strain lacking functional Ndufs4, a gene encoding a subunit required for complete assembly and function of complex I. Our preliminary data demonstrate that deletion of the Ndufs4 gene abolishes complex I activity in midbrain mesencephalic neurons cultured from embryonic day (E) 14 mice. However, dopaminergic neurons in these cultures appeared normal and healthy with no decrease in survival during culture compared to neurons from wild-type mice. In this proposal, we will use conditional Ndufs4 knock out mice to determine if complex I inhibition is a main mechanism underlying dopaminergic neuron degeneration induced by the MPTP and rotenone models of PD in vivo and to elucidate complex I inhibition-independent mechanisms of cell death.

Public health relevance
PUBLIC HEALTH RELEVANCE: Parkinson's disease is the second most common aging-related neurodegenerative disorder. We propose to elucidate molecular mechanisms underlying dopaminergic neuron death in vitro and in vivo. These mechanistic studies should provide critical information concerning the molecular basis of dopaminergic neuron death in several models of Parkinson's disease, and may provide important new insights concerning the molecular basis Parkinson's disease. 7. Project Narrative Parkinson's disease is the second most common aging-related neurodegenerative disorder. We propose to elucidate molecular mechanisms underlying dopaminergic neuron death in vitro and in vivo. These mechanistic studies should provide critical information concerning the molecular basis of dopaminergic neuron death in several models of Parkinson's disease, and may provide important new insights concerning the molecular basis Parkinson's disease. __SpecificAimsTextDelimiter__ Research Plan 2. Hypothesis and Specific Aims Parkinson's disease (PD) is the second most common aging-related neurodegenerative disorder [14]. It is characterized by selective loss of dopaminergic neurons in the substantia nigra pars compacta (SNpc) of the brain. Despite intense research in the past decade, mechanisms underlying selective dopaminergic neuron death are not well defined. Inhibition of mitochondrial complex I has been proposed as one of the leading hypotheses [15]. However, this hypothesis had not been tested genetically. Our collaborator, Dr. Richard Palmiter, generated a transgenic mouse strain lacking functional Ndufs4 in all cells starting from early embryonic development [16]. Ndufs4 is a gene encoding a subunit required for complete assembly and function of mitochondrial complex I. We recently published evidence that deletion of the Ndufs4 gene in this mouse strain abolishes mitochondrial complex I activity in midbrain mesencephalic neurons cultured from embryonic day (E) 14 embryos (Fig. 3-4 and [13]). However, dopaminergic neurons in these cultures appeared normal and healthy with no decrease in survival in culture (Fig. 5-7). Treatments of cultured neurons or rodents with rotenone or MPTP are often used to model selective dopaminergic neuron death associated with sporadic PD. Rotenone and MPP+, the toxic metabolite of MPTP, are known inhibitors of mitochondrial complex I and it is generally thought that their toxicity to dopaminergic neurons is mediated by complex I inhibition. If this is true, then MPTP or rotenone toxicity should be abolished or reduced in the absence of complex I activity since their toxic target is removed. Surprisingly, dopaminergic neurons from Ndufs4-/- mice lacking complex I activity were not protected at all from MPP+ or rotenone (Fig. 8, 10). These data challenge the complex I inhibition theory and suggest the interesting possibility that there is a complex I-independent mechanism that renders dopaminergic neurons more susceptible than other neurons to rotenone and MPP+. We hypothesize that complex I inhibition by itself is not sufficient to induce dopaminergic neuron death and that the toxicity of rotenone and MPP+ for dopaminergic neurons does not depend on complex I inhibition. Part of the goals of this proposal is to use conditional complex I knockout (KO) mice to test these hypotheses in vivo (Aims 2 and 3). We also propose depolymerization of microtubule, inhibition of vesicular monoamine transporter (VMAT) 2, accumulation of cytosolic dopamine and reactive oxygen species (ROS) as an alternative mechanism responsible for rotenone-induced, complex I-independent dopaminergic neuron death. This alternative hypothesis is schematically illustrated in Fig. 1 and will be tested both in vitro (Aim 1) and in vivo (Aims 2 and 3). Fig. 1. Hypothesis model. Rotenone-induced, complex I-independent dopaminergic neuron death may be due to microtubule depolymerization and VMAT2 inhibition, which increase total and cytosolic dopamine, leading to increased ROS and cell death. Specific aims are to: Aim 1: Elucidate rotenone-induced, complex I-independent, dopaminergic neuron death mechanisms in primary cultures. Our preliminary data presented in Fig. 11-20, also summarized in point #3 of the Introduction, lead us to hypothesize that rotenone causes microtubule depolymerization and VMAT2 inhibition, which increase total and cytosolic dopamine, leading to increased ROS and cell death. To further test our hypothesis, we will perform biochemical assays to determine if rotenone binds to microtubules and inhibits VMAT2 activity in Ndufs4+/+ and Ndufs4-/- cultures. We will employ additional complementary pharmacological approaches to interfere with microtubule stability, VMAT2 function, dopamine metabolism and ROS production. Furthermore, we will use molecular approaches, including expression of various proteins or siRNA to modulate VMAT2 protein expression and function, and to promote either the stabilization or de-polymerization of microtubules. Using this combination of pharmacological and molecular approaches, we will determine if microtubule depolymerization and VMAT2 inhibition play a critical role in rotenone-induced dopaminergic neuron death. We will also determine if VMAT2 inhibition is downstream from rotenone-induced microtubule depolymerization. If our hypothesis is true, exposure to toxicants that disrupt microtubule dynamics and VMAT2 function may be a risk factor for PD. Aim 2: Examine spontaneous as well as MPTP- and rotenone-induced dopaminergic neuron death in vivo using a mouse strain in which complex I is conditionally ablated in dopaminergic neurons. Although our data demonstrate that Ndufs4 deletion and loss of complex I activity have no effects on basal cell death and do not attenuate MPP+ and rotenone toxicity in primary cultured dopaminergic neurons in vitro (Fig. 5-10), it is critical to validate these results in vivo using animal models because in vitro results do not always reflect what occurs in vivo, in the intact animal. Dissociated, cultured neurons lack cell-cell interactions present in vivo, including neuron-neuron, neuron-astrocyte, and neuron-microglia interactions which may impact the susceptibility of dopaminergic neurons to cell death stimuli and affect signaling pathways contributing to cell death. The Ndufs4 gene was deleted in all cells during early embryonic development in the Ndufs4-/- mouse strain used for our in vitro studies reported in "Preliminary studies". These mice die at post-natal week 7 [16] and therefore cannot be used for in vivo experiments. We have crossed Ndufs4lox/lox mice with mice in which the codon-improved Cre recombinase gene (iCre) is under the control of the promoter for dopamine transporter (DAT) [17] to achieve conditional Ndufs4 deletion in dopaminergic neurons. The Ndufs4lox/lox¿DAT-iCre mice are in a homozygous ROSA26 Cre reporter background (R26Rlox/lox) [18] to facilitate the detection of DAT-iCre- mediated recombination events in vivo. We have generated the Ndufs4lox/lox¿R26Rlox/lox¿ DAT-iCre mice. These mice are healthy and fertile, exhibit Cre-mediated recombination only in dopaminergic neurons, and have survived 3 weeks after the last dose of MPTP treatment, after which time they were sacrificed (Fig. 22). Using these dopaminergic neuron specific Ndufs4 KO mice, we will measure spontaneous degeneration as well as MPTP- or rotenone-induced toxicity of dopaminergic neurons in vivo. In addition, we will evaluate our alternative, complex I-independent cell death hypothesis, identified in Aim 1, in vivo. Specifically, we will determine if rotenone causes microtubule depolymerization and VMAT2 inhibition in these mice, if viral expression of VMAT2 attenuates, while siRNA to VMAT2 exacerbates rotenone toxicity in vivo. Aim 3: Examine spontaneous as well as MPTP- and rotenone-induced dopaminergic neuron death in vivo using a mouse strain in which complex I is conditionally ablated in all cells. It is known that human PD patients display decreased complex I activity not only in dopaminergic neurons but also in many other tissues including muscle and platelets [19-21]. More importantly, other cells in the brain, including non- dopaminergic neurons, astrocytes, oligodendrocytes, or microglial, may influence dopaminergic neuron survival. For example, non-dopaminergic neurons and neurotransmitters including noradrenaline can modulate MPTP toxicity [5]. Astrocytes and microglial activation have been implicated in dopaminergic neuron death in the rotenone and MPTP models of PD [6-10]. In fact, some investigators claim that the primary effect of rotenone is on microglia which secret toxic factors including superoxide to kill dopaminergic neurons [6, 11, 12]. Consequently, while disruption of complex I activity specifically in dopaminergic neurons may or may not have an effect on their survival, ablation of complex I activity in other types of cells in the brain may indirectly affect the susceptibility of dopaminergic neurons to cell death in vivo. We have obtained Ndufs4lox/lox¿R26Rlox/lox¿Ubc-Cre-ERt2 mice to conditionally delete Ndufs4 gene in all cells of adult mouse brain by tamoxifen treatment. The Cre-ERt2 fusion gene is under the control of the human ubiquitin C promoter which is expressed in all cells; the Cre recombinase is activated upon tamoxifen treatment [22]. As with the dopaminergic neuron specific Ndufs4 KO mice in Aim 2, these tamoxifen-inducible, systemic KO mice are also in the R26R background to facilitate the detection of cells that have undergone Ubc-Cre- ERt2-induced recombination in vivo. The Ndufs4lox/lox¿R26Rlox/lox¿Ubc-Cre-ERt2 mice are healthy and fertile before tamoxifen treatment. Dr. Palmiter, our collaborator, established that tamoxifen reduces Ndufs4 protein expression by about 80% and these mice survive for at least 8 months after tamoxifen treatment (Fig. 23). These tamoxifen-treated mice provide a genetic model for partial systemic loss of complex I activity in vivo. Our recent data showed that these tamoxifen-treated KO mice survive 3 weeks after the last dose of MPTP treatment, after which time they were sacrificed. We will examine the effect of complex I deficiency in all cells of the adult brain on spontaneous as well as MPTP- and rotenone-induced degeneration of dopaminergic neurons in vivo. Using general methods outlined in Aim 2, we will evaluate the role for microtubule depolymerization and VMAT2 inhibition in complex I-independent rotenone toxicity in vivo in these mice.